Identification of Procedural, Genetic and Psychosocial Risk Factors for ChronicPost-Amputation Pain

Chronic Post-amputation Pain (cPAP) is a major unsolved healthcare problem. Every year, Veterans Health
Administration (VHA) hospitals perform 7,000 amputations and civilian hospitals perform approximately
115,000 amputations. Between 50 and 90% of Amputees will suffer from cPAP, with impaired psychological
well-being, physical disability, and a substantially lower quality of life in those patients affected, in addition to
the cost to society at large. Even novel surgical methods such as regenerative peripheral nerve interface
surgery can only modestly reduce, but not prevent, cPAP. Once cPAP has developed, treatment is very difficult
with few therapeutic options. Despite the high clinical relevance, there are still critical gaps in our knowledge of
cPAP and its pathophysiology. Our proposal is focused on addressing three of these gaps using the framework
of the Million Veteran Program (MVP).
The first Specific Aim is to describe the demographics of the MVP Amputee cohort, and the incidence of cPAP
in that cohort. This will be defined as point prevalence 9 (± 3) months after amputation. The complementary
outcome measures are the incidence and severity of cPAP over time, as well as 1- and 5-year mortality. This
will give us a solid understanding of the Amputee cohort within MVP. In addition, we will describe the
perioperative care these patients received around their amputation, and the access to care they had after
surgery, and whether these factors are associated with the development of cPAP. At completion of Specific Aim
1, we will have created a valuable MVP-specific phenotype for well-conducted genetic studies, which will also
facilitate studies by other researchers. We will have also assessed the patterns of practice, the access to care,
and the resulting time-course and severity of cPAP in MVP patients.
The second, and central, Specific Aim of this proposal is to identify genetic variants that are associated with
cPAP risk in MVP patients. This will serve three purposes: first, it will allow us to better understand the genetic
basis for individual risk to develop cPAP; second, it will allow us to describe the congruence of genetic risk
factors between cPAP and diagnoses which we know to influence pain conditions, in particular chronic non-
cPAP pain, anxiety, depression, PTSD, schizophrenia and substance use disorders; and third, this Aim will
shed light on biological-pathway based risk factors specific for cPAP, which may help identify therapeutic or
preventive candidate therapies going forward. At completion of Specific Aim 2, we will have characterized the
influence of genetic factors on the occurrence of cPAP while accounting for genetic risks of highly correlated
psychosocial risks.
The third Specific Aim of this proposal is to examine patient-specific health characteristics, including
psychosocial factors and Social Determinants of Health (SDOH). Despite strong evidence in other domains,
the relationship between psychosocial factors, SDOH, and the development of cPAP is currently unknown. At
completion of Specific Aim 3, we will have developed a holistic approach to the risk factors underlying cPAP by
assessing patient-specific and social determinants of health as they relate to the development of cPAP.
This proposal breaks ground for a future line of research aimed to inform a comprehensive risk score to assess
amputees’ risks of developing chronic pain. Data regarding the occurrence of PAP, the associated genetic
variants, the interventions that might have a beneficial effect on patient outcome, and the psychosocial and
demographic risk factors will offer new insights for assessment, interventions and improvement in meaningful
patient-centered outcomes after amputation surgery.

Public health relevance
Chronic Post-amputation Pain (cPAP) is a major unsolved healthcare problem, especially prevalent in the Veteran population, and notoriously difficult to treat. We seek to answer key clinical questions that will improve patient management using the framework of the Million Veteran Program (MVP). First, we will identify a robust multi-faceted MVP-specific phenotype for cPAP that will serve future studies by our team and other researchers. The core, second aim of this proposal is to identify common and rare genetic risk factors for cPAP and its genetic overlap with related disorders such as anxiety, depression and PTSD. Finally, we will model the effects of perioperative management and psychosocial factors and Social Determinants of Health on the development of cPAP. This proposal supports a future line of research aimed to inform a comprehensive risk score to assess amputees’ risks of developing chronic pain, and to potentially identify novel therapeutic interventions via identification of pathways genetically associated with cPAP.